Neurovascular Plasticity

DESCRIPTION (provided by applicant): For the last 30 years, there has been a growing recognition that adult plasticity is a fundamental mechanism underlying a host of brain processes ranging from recovery after injury to learning and memory and involves multiple levels of the brain including synapses, neurons, neuronal circuits, representational maps, and even supporting metabolic and vascular systems. Enhancement of neuronal plasticity as a means of treatment of neurological disorders and injuries has not been fully utilized, although such treatments are an attractive alternative to more conventional treatments because they have few, if any, side effects. Could plasticity be exploited for protection from brain injury? We propose the hypothesis that one type of plasticity, neurovascular plasticity, could be exploited to completely protect the cortex from ischemic injury. The proposed multifaceted study is designed for detailed quantification to further answer specific hypotheses related to protection by neurovascular plasticity and its underlying mechanisms at the functional, metabolic, histological, vascular, and behavioral levels in both adult and old rats.

Public health relevance
PUBLIC HEALTH RELEVANCE: The brain, and especially the cortex, is plastic (i.e., mutable) as demonstrated for many brain processes ranging from recovery from injury to learning and memory. Could plasticity be further exploited to protect it from brain injury? Based on new findings from our laboratory, we propose the hypothesis that one type of plasticity, neurovascular plasticity, could indeed be exploited to completely protect the ischemic injury (stroke) in adult and old rats. PROJECT NARRATIVE The brain, and especially the cortex, is plastic (i.e., mutable) as demonstrated for many brain processes ranging from recovery from injury to learning and memory. Could plasticity be further exploited to protect it from brain injury? Based on new findings from our laboratory, we propose the hypothesis that one type of plasticity, neurovascular plasticity, could indeed be exploited to completely protect the ischemic injury (stroke) in adult and old rats. __SpecificAimsTextDelimiter__ Specific Aims The long-term research interest of our laboratory is to understand plasticity in the adult sensory cortex and its implications for the functional organization of the cortex. For the last 30 years, there has been a growing recognition that adult plasticity is a fundamental mechanism underlying a host of brain processes ranging from recovery after injury to learning and memory, and involves multiple levels of the brain including synapses, neurons, neuronal circuits, representational maps, and even supporting metabolic and vascular systems. Enhancement of neuronal plasticity as a means of treatment of neurological disorders has not been fully utilized, although such treatments are an attractive alternative to more conventional treatments because they have few, if any, side effects (Moller, 2006). For example, physical therapy after brain injury (e.g., ischemic injury) is a clear example of enhancing plasticity for regaining lost function, but more advanced and directed methods to enhance plasticity, such as electrical stimulation of the cortex, have also demonstrated their capacity to enhance rehabilitation after ischemic injury (Moller, 2006). Could plasticity be further exploited not only for post-injury recovery, but also to protect from brain injury? We propose the hypothesis that one type of plasticity, neurovascular plasticity, could be exploited to completely protect the cortex from ischemic injury. Our model animal system is the somatosensory cortex of the rat, with a focus on its largest subdivision known as the "barrel cortex". The barrel cortex is one of the most studied models of cortical structure, function, and plasticity in neuroscience research due to its exquisitely ordered maps of anatomical and functional representations of the large facial whiskers. Our laboratory pioneered the use of high-resolution functional imaging of whisker representations in barrel cortex. For the last sixteen years, we have routinely performed high-resolution functional imaging, electrophysiological recordings, and post-mortem histology of the functional and anatomical representations of whiskers in barrel cortex to study cortical functional organization and its plasticity, as reviewed by (Frostig, 2006). Here, we propose a new set of studies on cortical plasticity based on our new findings obtained by using the rat's barrel cortex as a model of ischemic brain injury. Ischemia is induced in adult rats by permanent occlusion (ligation) of the middle cerebral artery, a major artery supplying blood to large portion of the cerebral cortex both in humans and rats. Our new findings show that if patterned mechanical stimulation of a single whisker starts within 1 hour following occlusion, it induces neurovascular plasticity that protects the cortex from impending ischemic injury - a finding that we have corroborated using multiple techniques. Whisker stimulation is not protective anymore if delivered three hours following occlusion, and the ischemic cortex is therefore injured. We propose to use our complementary set of techniques, including in addition to the ones described above, also quantitative imaging of cortical metabolism, blood flow, and behavioral assays to further investigate protection induced by neurovascular plasticity. The proposed experiments will provide a comprehensive, multi-level characterization of such plasticity and of its underlying mechanisms. Our specific aims are to investigate the following hypotheses: 1) Hypothesis 1: Protection depends on the level of evoked cortical activity: therefore increasing the level of evoked cortical activity within 1 hour post MCAO would lead to faster recovery. The same increase of evoked cortical activity 3 hours post MCAO, however, would lead to a major increase in the volume of ischemic injury. 2) Hypothesis 2: Protection from ischemic injury can also be obtained by using a cortical stimulating electrode(s) that mimics cortical activation by whisker stimulation - using optimal stimulation parameters obtained from aim1 studies. This is the first step towards implementation of transcranial stimulation. 3) Hypothesis 3: The underlying neurovascular pathway responsible for stimulus-induced reperfusion of the ischemic area by reversal of blood flow within the MCAO, involves neuron-astrocyte interaction. We propose to apply specific pharmacological blocking agents to confirm the role of astrocytes in this pathway. 4) Hypothesis 4: Protective mechanisms studied in young adult rats (aims 1-3) are also relevant to old rats. Since the largest population of human ischemic injury victims is comprised of older adults, we propose to readdress the goals of aims 1-3 on a population of aged (20 months) rats. The proposed research will provide, for the first time, a detailed quantitative and multi-level, multi-scale characterization of protective neurovascular plasticity, and will also help to start elucidations of mechanisms underlying such plasticity in the adult and aged mammalian brain. We anticipate that findings obtained from these studies could be applicable in the future to the protection of ischemic injury in the human brain.